Role and Regulation of Cellular Polarity in Craniofacial Skeletogenesis

Project Summary
A functional skeletal system depends on the coordinated development of cartilages and bones during
embryogenesis. However, little is known about the cellular and molecular mechanisms that control the
polarized growth of cartilages, which determine endochondral bone size and shape. Unraveling the
signals that direct mesenchymal cells to condense and align into pre-chondrogenic stacks is key to
understanding early events that shape the organization and growth of the skeleton. Elucidating these
processes will allow better diagnosis and treatments for skeletal malformations and birth defects.
Moreover, molecules that control cartilage morphogenesis and differentiation may be of considerable
clinical importance both for improvements in diagnosing and treating congenital birth defects as well as
developing mesenchymal stem-cell based therapies for skeletal disorders. Evidence that
planar cell polarity pathways are essential for cartilage cells to stack properly, suggests a previously
unappreciated mechanism for patterning cartilage growth plates of long bones as well as growth zones
in bones of the skull. Dramatic results from many laboratories now demonstrate that Dlx transcription factors
regulate planar cell polarity signaling, well known for its critical roles in long bone growth plates, as well as
craniofacial cartilage polarity in zebrafish. Embryos deficient in Dlx5 and Dlx6 show defects in cartilage
stacking, like mutants in Wnt5b and Ror2. Moreover, comparisons of cartilage growth zones in African cichlid
fishes that have evolved dramatically different craniofacial bone shapes, reveal that growth zone size
differences during larval development correlate with these species-specific shapes. Aim 1 will build upon
previously funded work to address the hypothesis that Dlx5/6 directly regulate pharyngeal arch patterning and
growth zone formation via planar cell polarity. Cartilage phenotypes will be evaluated in embryos and larvae in
which Dlx5/6 have been genetically deleted and identify the polarity pathways regulated by Dlx5/6 as well as
the signaling and responding cells. Aim 2 will address the functions of Wnt5- as well as Fat3-mediated planar
polarity in early arch morphogenesis as well as later growth zones, including both transcriptional and non-
transcriptional modes of propagation such as cytosplasmic extensions called cytonemes. New transgenic tools
will allow tracking of polarity and visualization of cytonemes. Finally, Aim 3 will continue “evo-devo” projects
focused on discovering new genes involved in cartilage polarity and growth zones using quantitative trait locus
mapping in cichlids. Together, these studies will lead to mechanistic insights into the relatively unexplored
functions of cellular polarity in the vertebrate skeleton. This work will lead to insights into the causes of human
skeletal disorders of Dlx5/6, such as Split Hand Foot syndrome, as well as polarity disorders such as Robinow
and Van Maldergem syndromes.

Public health relevance
Project Narrative The proposed studies will provide some of the first evidence that cartilage polarity acts downstream of craniofacial patterning genes to influence skeletogenesis. Defining molecules that control cartilage development may be of clinical importance both for improving treatments for cartilage and joint injuries and in efforts to induce cartilage from stem cells. Dlx5 and Dlx6, as well as the Fat3 and Wnt5 signaling pathways are also implicated in birth defects, including Split Hand Foot and Robinow syndrome, and understanding their functions could help improve diagnosis and treatments for these and related diseases.